Attachment and Biobehavioral Catch-up with Child Protective Services-Involved Parents: Testing Effectiveness in the Community

PROJECT SUMMARY/ ABSTRACT
Young children who have experienced neglect or abuse are at increased risk for poor behavioral
and biological outcomes. However, this risk can be buffered if their parents behave in sensitive
ways. Attachment and Biobehavioral Catch-up (ABC), a home visiting intervention, targets
parental sensitivity among parents of high-risk infants. Through efficacy trials, the ABC
intervention has been shown to engage the intervention mechanism, parental sensitivity, and
enhance parental neural activity. In addition, children whose parents receive the ABC
intervention show better outcomes in attachment, cortisol production, and behavioral regulation
than children whose parents receive a control intervention. Pilot work suggests that some
parents respond to the intervention within several sessions, suggesting that an abbreviated
intervention could be optimal for them. The next critical step is demonstrating that the ABC
intervention engages the intervention mechanism when implemented by community clinicians in
a community context, and examining whether some parents can benefit from an abbreviated
version of the intervention.
This effectiveness trial leverages an existing partnership between a community-based
organization and child welfare system to examine whether the ABC intervention engages the
treatment mechanism, parental sensitivity, when implemented by community clinicians, whether
changes in parental sensitivity mediate intervention effects on child outcomes, and whether
parental cumulative risk moderates the effectiveness of varied dosages of the intervention.
A total of 360 parents and their young children involved in the New York City child welfare
system will be included as participants. Parents will be randomized to a screen-and-refer
intervention with an established evidence base (Safe Environment for Every Kid; SEEK), to
SEEK plus a 3-session version of ABC (ABC 3), or to SEEK plus the standard 10-session ABC
intervention (ABC 10). Intervention effectiveness will be examined as changes in parental
sensitivity (the intervention mechanism) at both behavioral and neural levels, as well as
changes in child outcomes. Changes in parental sensitivity are expected to mediate intervention
effects on child outcomes. Individual differences in response to treatment dosage will be
explored.

Public health relevance
PROJECT NARRATIVE Childhood maltreatment represents an urgent public health problem, as it is highly prevalent, significantly increases risk for chronically impairing mental health problems, tends to persist across generations, and is very costly to society at large. Leveraging an existing partnership between a community-based organization and child welfare system, this project will examine the effectiveness of the Attachment and Biobehavioral Catch-up (ABC) intervention, which targets sensitivity among parents who have maltreated their children. Findings will have substantial public health impact by assessing the effectiveness of the ABC intervention in a community context, identifying modifiable mechanistic pathways by which the ABC intervention may prevent later mental health problems, and identifying treatment moderators that may promote more targeted, cost-effective approaches to prevention.